The Military HIV Research Program (MHRP) Clinical Trial Unit

April 26, 2024
Gregg A. Roby, BS, RN, CCRP
Branch Chief, Africa and Domestic Partners Branch
Office of Clinical Site Oversight (OCSO)
Division of AIDS (DAIDS)
Ref: Grant Number: 5UM1AI108568-11
Principal Investigator: Merlin Robb, MD, PhD
Project Title: The Military HIV Research Program (MHRP) Clinical Trial Unit
Subject: Supplemental Funding
Dear Gregg Roby:
The Henry M. Jackson Foundation for the Advancement of Military Medicine, Inc. (HJF) hereby submits
a Supplemental Funding request.
Identifying individuals with multidrug resistant TB is the critical first step in PHOENIx MDR TB. It is
often the case that these cases and their families are located at some distance from the CRS clinic and
participants are currently being evaluated at the nearest Kenyan health clinic. In order to efficiently
maintain all required research activities, the KEMRI WRP site (CRS 12501) and Moi University Clinical
Research Center (MUCRC) are requesting purchase of a van configured to permit all activities required
for the PHOENIx study visit to include phlebotomy, storage of blood tubes pending processing at the
main CRS laboratory. Both the Kericho and Moi site will require these vans to obviate the use of
peripheral health clinics and accommodate the wide geographic dispersion of PHOENIx participants.
Please find the following documents attached for your review:
1. Budgets for both the KEMRI WRP site (CRS 12501) and Moi University Clinical Research
Center (CRS 32021)
2. Budget Justification
3. Vendor Quote per one vehicle
If you have any questions or if you require additional information, please contact Cheryl Patterson at 240-
694-2029 or by email to [email].
Regards,
Mai Apriyanto (On behalf of Heather Davids)
Sr. Grants Manager-Team Lead, Office of Sponsored Programs
Cc: Sufiyan Saeed, Grants Management Specialist

Public health relevance
Project Narrative Ref: Grant Number: 5UM1AI108568-11 Principal Investigator: Merlin Robb, MD, PhD Project Title: The Military HIV Research Program (MHRP) Clinical Trial Unit Subject: Supplemental Funding Identifying individuals with multidrug resistant TB is the critical first step in PHOENIx MDR TB. It is often the case that these cases and their families are located at some distance from the CRS clinic and participants are currently being evaluated at the nearest Kenyan health clinic. In order to efficiently maintain all required research activities, the KEMRI WRP site (CRS 12501) and Moi University Clinical Research Center (MUCRC) are requesting purchase of a van configured to permit all activities required for the PHOENIx study visit to include phlebotomy, storage of blood tubes pending processing at the main CRS laboratory. Both the Kericho and Moi site will require these vans to obviate the use of peripheral health clinics and accommodate the wide geographic dispersion of PHOENIx participants.